Neural circuitry and population dynamics for perception of social vocalizations in the auditory pathway

Project Summary
The ability to perceive and respond to vocalizations across behavioral contexts is key for survival, but the
mechanisms for how the brain derives meaning from acoustic features to drive appropriate behavioral responses
remain unknown. I will test the overall hypothesis that top-down control of feed-forward auditory circuits via
cortical projection neurons is critical for recognition of social calls and routing of sensory information to circuits
driving behavior. In the mentored (K99) phase, I will take advantage of an ethological mouse behavior studied
extensively in my postdoctoral lab, in which parentally-experienced mice search for lost pups in response to a
specific type of vocalization. Experienced moms are experts at this behavior, but it can also be learned by virgins,
and learning is correlated with plasticity in the left auditory cortex in females. Pup retrieval involves a complex
sequence of actions, and auditory cues may be required during specific epochs. I will build upon my pilot data
finding that cortical projection neurons are necessary for retrieval, and that exposure to pup calls drives sustained
activity in a distinct projection in experienced females. Aim 1 (K99) uses imaging and multi-area ensemble
recordings to ask how inter-area dynamics in recurrent auditory circuits change during pup calls compared to
non-vocal sounds with similar temporal structures, with the hypothesis that network activity is elevated
specifically during vocalizations to facilitate brain state modulation or communication with sensorimotor circuits
over time scales relevant for behavior. Synaptic mechanisms driving this persistent activity will be examined with
in vivo whole-cell recordings. Aim 2 (K99) will test which projection neurons are required for retrieval and over
what behavioral time scales. Animals vocalize in multiple situations to communicate distinct meanings – for
example, male calls to communicate aggression or courtship – and the brain must make sense of these calls,
using acoustic features as well as non-auditory context cues to distinguish between meanings. In the
independent phase (R00), Aim 3 asks whether calls are processed with neural ensembles and inter-area
dynamics that are generalized across categories or distinct for specific behavioral outcomes. Additionally, the
relevance of different social calls can change depending on an animal’s internal state. Aim 4 (R00) investigates
whether neural ensemble representations of male calls change in female mice as sexual receptivity varies,
measuring activity in cortical ensembles tracked over weeks of experience. In the mentored phase I will complete
a training plan designed to strengthen the experimental and computational skills needed for my research
program as an independent investigator, and to build the professional skills needed for success as a faculty
member, taking advantage of resources and expertise available from the mentor, advisory committee and
broader environment at NYU.

Public health relevance
Project Narrative Social animals depend on vocal communication for survival in many contexts, and the brain must extract information from acoustic features of calls and communicate with circuits for appropriate behavioral responses. Depending on the call meaning, this processing must occur over time scales needed for guiding various behaviors. The research proposed here tests the overall hypothesis that top-down circuits in the auditory system facilitate vocalization-guided behaviors across contexts, using multiple methods for monitoring and manipulating activity in neurons and ensembles to dissect the circuits involved in driving behavior.